TARGETING OF PROTEINS TO THE PROTEASOME DURING SPERMATOGENESIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Using a combination of genetic and proteomic techniques, we are searching for novel proteins which are involved in the targeting of proteins to the proteasome during spermatogenesis in D. melanogaster testes, and are therefore involved in cell death.